A CLINICAL TRIAL OF LOW MOLECULAR WEIGHT HEPARIN TO PREVENT THROMBOSIS

Sixteen patients have been accrued to determine whether daily enoxaparin injections will prevent deep vein thrombosis related to venous access devices.